Structure-based Vaccine Design for CCHFV

Project Summary/Abstract
Crimean-Congo hemorrhagic fever virus (CCHFV) causes a life-threatening tick-borne disease in humans.
The disease presents as a severe form of hemorrhagic fever with a case fatality rate of 10–40%. CCHFV
outbreaks have spanned a wide geographic area ranging from Western and Central Asia, the Middle East,
Africa and Southern Europe. Increasing global temperatures, migratory birds, and the international livestock
trade have all potentially contributed toward the spread of Hyalomma ticks—the primary vector for CCHFV.
Expanding endemic zones, widespread morbidity and significant mortality make CCHFV an acute threat to
public health and thus is listed as a NIAID Category A priority pathogen. The viral genome encodes a
glycoprotein precursor that is processed into two structural glycoproteins—Gn and Gc—and two secreted
glycoproteins—a mucin-like domain and GP38. Protective antibodies have been isolated that target Gc or
GP38, suggesting that these two proteins should be given priority for vaccine development. Here we
propose to engineer Gc- and GP38-based immunogens that focus the immune response onto broadly
conserved epitopes that are capable of eliciting protective antibody responses. To accomplish our goal, we
will structurally characterize CCHFV glycoproteins and their interactions with human-derived antibodies,
rationally engineer vaccine antigens based in part on the structural information, and characterize the
immune responses elicited by these antigens in animal models. These results will be used to guide further
improvements of the immunogens, including display on self-assembling multi-valent nanoparticles, and the
most promising candidates will be evaluated in a lethal murine model of CCHFV challenge. Given our
expertise, unique reagents, and preliminary data, we are confident that we can deliver a state-of-the-art
subunit vaccine candidate with the potential to induce cross-reactive protective antibodies, thereby
satisfying an unmet need against this NIAID Category A tick-borne pathogen.

Public health relevance
Project Narrative Crimean-Congo hemorrhagic fever is the most widespread tick-borne viral disease in humans with case- fatality rates of 10–40%. Here we propose to employ structure-based vaccine design principles to engineer immunogens that induce cross-reactive protective antibodies. Our studies will provide insight into the structures and antigenicity of CCHFV glycoproteins and will deliver a bona fide vaccine candidate against a NIAID Category A pathogen.